Neural mechanisms underlying the restructuring of olfactory representations in the Drosophila mushroom body

Project Summary/Abstract
Understanding the axes that organize the large and diverse space of odor stimuli for efficient encoding and
decoding is a core challenge in olfaction. In addition to their physicochemical properties and molecular features,
an important property of odorants is how they are organized relative to one another in natural environments. We
hypothesize that the statistics of odorant correlations in natural settings, shaped by conserved metabolic and
biochemical pathways in behaviorally important odor sources, are important to extracting information about the
identity and ethological value of the source. To understand how animal brains accomplish this task, we trace
how odors are formatted and encoded at successive stages of neural processing in the olfactory system of the
vinegar fly Drosophila melanogaster.
We recently discovered that the fly olfactory code is unexpectedly restructured between primary olfactory
receptor neurons (ORNs) at the periphery and the mushroom body (MB), a third-order associative olfactory
processing region. Specifically, odor relationships encoded in the MB better reflect the relationships of
monomolecular volatiles in behaviorally relevant natural sources, compared to their similarity with respect to
chemical features, and the converse was true for odor relationships encoded in peripheral ORNs. The goal of
this project is to understand the principles and neural mechanisms underlying this restructuring, guided by the
hypothesis that this process reflects the progressive reformatting of the olfactory code to encode variables
relevant to behavioral significance. To achieve this goal, Aim 1 will test the hypothesis that an important
organizing principle for olfactory coding and behavior is the metabolic relationship between odorants, structured
by conserved biochemical processes in natural odor sources; Aim 2 will systematically map the transformation
of odor representations at each synaptic stage of olfactory processing, thereby elucidating the neural circuit
mechanisms that underlie these transformations; and Aim 3 will determine how neural activity and olfactory
experience contribute to the structure of olfactory codes in the MB.
Our research plan describes how we will achieve these goals by leveraging the well-mapped connectivity of the
fly nervous system, the ability to selectively measure and manipulate neural activity in defined neural populations,
and the adaptation of geometric approaches, originally developed for understanding human visual perceptual
spaces, as a computational framework for mapping how olfactory representational spaces are transformed along
the fly olfactory pathway. This project will advance our understanding of the broad and important problem of how
sensory systems capture natural stimulus structure and use it to progressively reorganize sensory
representations into formats useful for making semantic inferences about objects in the natural world in relation
to their behavioral needs.

Public health relevance
Project Narrative This project investigates the organizational logic and neural mechanisms the brain uses to represent and extract meaning from smells in the natural world. Abnormal sensory processing and deficits in perception impair the ability of millions of Americans to interact normally with their environment, in the context of neurodegenerative disorders, like Alzheimer’s and Parkinson’s disease, as well as neurodevelopmental and neuropsychiatric conditions, like autism spectrum disorders or schizophrenia. This project will advance our understanding of the basic principles of hierarchical sensory processing in animal brains by elucidating the computations and circuit mechanisms by which sensory information is encoded and transformed into formats that support perception and behavior.